Evaluating the effects of reproductive health training on provider behavior (Supplement)

Abstract
In sub-Saharan Africa, an environment with the world’s highest rates of human immunodeficiency virus, STIs,
and multiple sexual and reproductive health challenges, training of health students in sexual healthcare is
almost non-existent. This study is sited in Tanzania (Tz), a socially conservative, highly religious country where
34% of the population are Muslim. There are 13 health universities in Tz: 5 secular, 6 Christian-affiliated and 2
Muslim-affiliated. In our Training for Health Professionals RCT (N=412 students), the medical, nursing and
midwifery students who received our comprehensive sexual health curriculum had moderate-to-large increases
in sexual health knowledge, improved attitudes, and improved clinical skills compared to controls. Reflecting
national statistics, 92% of students rated themselves “moderately” to “extremely” religious. Effects did not differ
by discipline or demographics, but in secondary analyses, two religious differences were noted. Students who
were Muslim showed a smaller increase in confidence in their sexual health knowledge scores than Christian
students (β=-21.01, SE=6.53, p=.001). And while students agreed or strongly agreed that the curriculum was
respectful across several demographics (97%), and sexual values (85%), the lowest acceptability ratings were
for “religion and religious background” (70.3%). These analyses were exploratory as our study was not
powered to detect religious differences and only 14.3% participants were Muslims. In our renewal award, in
Aim 2, we are developing a train-the-trainer curriculum then will pilot the training to faculty at two other health
universities: University of Dodoma (UDOM) and Kilimanjaro Christian Medical College (KCMUC), both
Christian majority student bodies. In Aim 3, we will conduct a Phase IV trial at both sites with 3-, 6-, and 12-
month follow-up. This supplement is to bring in sexual health experts who are Muslim to advise our curriculum
and to add a third site. After the State University of Zanzibar (SUZA) learned about our study, they expressed
interest in being involved. SUZA is a secular health university with majority Muslim students. Adding SUZA as
a site will increase the likelihood for our project to exert a sustained, powerful influence on science and health.
Ethically, highly religious students are likely to be the students most in need of sexual health education. Adding
a Muslim majority site will increase our power to study effects by religious affiliation and religiosity. Showing
this curriculum was acceptable to Muslim students and increased their knowledge, attitudes, and clinical skills
will inform generalizability and has high potential to decrease religious objections to the curriculum. This in turn
will increase the likelihood of wide adoption of this curriculum in Muslim countries and across LMICs where
Muslim-affiliated universities provide significant health student training.

Public health relevance
Narrative In Tanzania, where most health students are moderately to highly religious including 34% of the population who are Muslim, it is important to study the effects of our curriculum by religious affiliation. Adding the State University of Zanzibar (SUZA) as a study site will help us research how comprehensive sexual education can be effectively delivered to students in a culturally and religiously respectful manner. Adding SUZA as a study site will help us test generalizability of our findings making it more likely for other Muslim majority universities and countries to adopt the curriculum.